Mechanisms that specify subtypes of photoreceptors for color vision

Project Summary/Abstract
Color vision requires the expression of opsins with different wavelength sensitivities in specific subtypes
of photoreceptor (PR) neurons. The molecular mechanisms that control these spatially precise, PR subtype-
specific expression patterns remain poorly understood. The long-term goal of the proposed project is to use
the Drosophila melanogaster retina as a model to decipher the cis-regulatory mechanisms and identify
conserved trans-acting factors that specify different subtypes of PR neurons for color vision.
We recently discovered that the gene regulatory network that mediates a blue- vs. green-sensitive PR fate
decision in the Drosophila retina involves the orthologs of four conserved transcription factors
(Otd/Otx2/Crx, Tj/Nrl, Hr3/Rorβ, and Blimp-1/Prdm1) that promote rod PR fate in the mammalian eye and
have been associated with severe human retinopathies. In the current proposal, we will determine how a
binary switch controls the blue- vs. green-sensitive PR fate decision through a differential regulation of the
conserved Hippo tumor suppressor pathway. In preliminary experiments, we discovered that the conserved
transcription factor H6-like-homeobox (Hmx/HMX1-3) is specifically expressed in blue PRs, where it
promotes blue PR fate by repressing the Hippo pathway as a crucial component of a positive feedback loop.
Notably, Hmx’s human ortholog HMX1 has been associated with severe eye and ear defects known as
Oculoauricular Syndrome. We will unravel how Hmx interacts with core components of the Hippo pathway
and identify its genomic targets (Aim 1). Moreover, we will investigate how a transient developmental
signal is transduced into a permanent subtype-specific Hmx activation and decipher the underlying cis-
regulatory logic (Aim 2). Lastly, we will investigate the role of cofactors in Hmx’s functions in different
ocular contexts and analyze the functions of Hmx’s highly conserved domains (Aim 3).
In conclusion, the proposed studies are significant and innovative because they will yield fundamental
insights into the regulatory logic of opsin expression and photoreceptor diversity by elucidating how cis-
regulatory mechanisms and conserved trans-acting factors, which have been associated with human
retinopathies, generate different subtypes of photoreceptor neurons for color vision.

Public health relevance
Project Narrative Color vision requires the expression of opsins with different wavelength sensitivities in specific subsets of photoreceptor neurons. However, the mechanisms that generate these spatially precise, non-overlapping opsin expression patterns remain poorly understood. The proposed project uses the Drosophila melanogaster retina as a model to decipher the underlying cis-regulatory mechanisms and identify conserved trans-acting factors that specify subtypes of photoreceptors for color vision.